Evaluating the causal effects of anti-malarial chemoprevention in pregnancy and childhood on growth outcomes

PROJECT SUMMARY
Malaria and growth faltering continue to be major causes of child morbidity and mortality in sub-
Saharan Africa where over 400,000 children under the age of 5 die from malaria1 and 57 million children are
stunted2 each year. Given the high co-prevalence of these conditions in the region, interventions that
synergistically address both malaria and growth failure may have a larger impact on child health than individual
efforts to prevent either condition.3 There is increasing evidence that malaria infections in pregnancy and
childhood may contribute to poor growth outcomes through increased risks of low birthweights4–9, systemic
inflammation10–15, and gut microbiome dysbiosis16–19. Maternal and neonatal factors are the most influential for
child growth20–22, so there is a critical need to identify interventions that prevent these malaria-associated risks
in pregnancy and early childhood to reduce long-term growth faltering. Intermittent preventative treatments in
pregnancy (IPTp) and childhood (IPTc), where pregnant women and young children are regularly given anti-
malarial drugs, have emerged as key strategies to control malaria in high-transmission settings. These
treatments have been shown to effectively lower malaria infections and could subsequently improve child
growth outcomes, but no prior studies have systematically assessed the impact of IPTp and IPTc on growth
faltering. Here, we propose a study that aims to (1) evaluate the effect of IPTp and IPTc on child growth and
(2) investigate the causal pathways through which IPTp and IPTc affect child growth. We will leverage rich,
longitudinal data from two ongoing randomized trials of IPTp and IPTc in Uganda, allowing us to measure child
height and weight, inflammatory biomarkers, and gut microbiome composition over several years. Our findings
will improve our understanding of how malaria chemoprevention impacts child growth and may guide the
implementation of future interventions that target both malaria and growth faltering. This award will also
support the career development of Anna Nguyen, a doctoral student in the Department of Epidemiology and
Population Health at the Stanford School of Medicine. Through completing the proposed research, the
applicant will pursue training in (1) the epidemiology of maternal and child malaria, (2) causal inference
methods for longitudinal data, (3) gut microbiome data analysis for population health research, and (4)
responsible conduct of global health research. The applicant will be supported by a mentorship team
comprising of experts in casual inference methods, malaria intervention trials, gut microbiome analyses, and
global health research. Through this fellowship, the applicant will develop strong methodological skills, gain
subject expertise, and become a more independent epidemiologic researcher. The proposed study will provide
a strong foundation for the applicant’s future academic research career and position her to become a leader in
casual inference, infectious disease epidemiology, and global health.

Public health relevance
PROJECT NARRATIVE In sub-Saharan Africa, malaria and growth failure continue to threaten child health and survival. Intermittent preventative treatment in pregnancy (IPTp) and childhood (IPTc) are promising strategies for malaria control that may also improve growth outcomes through the prevention of mediating factors such as low birthweight, systemic inflammation, and gut microbiome dysbiosis. In this proposed study, we will use causal inference methods to estimate the direct and indirect effects of IPTp and IPTc on child growth.